Training Grant in Genetics

Project Summary/Abstract
The proposed Training Grant in Genetics is the centerpiece in efforts to provide postdoctoral research training
in medical genetics in the Harvard Medical School (HMS) Genetics Training Program (HMSGTP) with an overall
goal to train future academic leaders of this discipline. The requested number of trainees per year is eight, and
these individuals comprise physicians and Ph.D.s undertaking medical genetics research. Physicians will join
the training program largely with experience in a variety of medical specialties, having done residency training
in a relevant discipline or enrolled in ACGME combined residency programs with medical genetics and genomics
(MGG). Ph.D.s may be appointed after completing training in ACGME MGG laboratory specialties or training in
laboratories pursuing foundational research in human genetics. The ACGME programs may lead to ABMGG
board certification. Advances in genetics and genomics, in particular the sequencing of the human genome, have
dramatically accelerated the pace of research in this area. Genetics and genomics are currently major drivers of
medical research and are leading to advances in diagnosis and treatment of both rare and common disorders.
Implementation of the many advances in genetics requires a well-educated, diverse and talented workforce of
genetics professionals. This Training Grant in Genetics has made possible training of physicians and scientists
in a wide variety of topics in medical genetics, enabling them to take advantage of the extraordinarily rich
academic environment present at HMS and its affiliated institutions as well as the greater Boston scientific
community notably including the Broad Institute. In addition, it has served to promote interactions between
medical geneticists and investigators and provided a forum for increasing faculty contact with trainees in didactic
sessions. Training laboratories of the HMSGTP have historically been centered now for five decades at HMS
and its affiliated institutions including Brigham and Women’s Hospital (BWH), the HMS Department of Genetics,
Beth Israel Deaconess Medical Center (BIDMC), Boston Children's Hospital (BCH), Dana Farber Cancer Institute
(DFCI), and Massachusetts General Hospital (MGH), and also include laboratories at Massachusetts Institute of
Technology (MIT) and the Broad Institute. Since the last renewal of this training grant, an ever enlarging variety
of opportunities in genomic medicine have developed to enhance the focus of training in medical and human
genetics, and the program is fully integrated in HMSGTP, accredited by the ACGME in Clinical Genetics and
subspecialties of Medical Biochemical Genetics and Molecular Genetic Pathology and combined training with
Clinical Genetics leading to dual board certification (Internal Medicine/MGG, Pediatrics/MGG, Maternal-Fetal
Medicine/MGG, with an application underway for training in Reproductive Endocrinology and Infertility/MGG),
Clinical Biochemical Genetics and Laboratory Genetics and Genomics, providing the opportunity for trainees to
become active candidates for certification in a discipline(s) of medical genetics in addition to receiving research
training for two to three years.

Public health relevance
Project Narrative The proposed program provides postdoctoral research training in medical genetics with an overall goal to train future academic leaders who will apply this knowledge to an understanding of human genetic disorders. Through rigorous training in the principles of genetics, trainees will exploit recent advances in genetics and genomics to discover the pathogenesis and pathobiology of inherited disease, and to use this information to improve human health. Understanding the etiology of heritable disease will lead to molecular classification, inform risk of recurrence, facilitate development of novel and more effective therapies to reduce illness and disability, and has potential to reduce costs in healthcare through stratification of patients for treatment and management based on the underlying genetic basis of their conditions.